CRCNS: Multiple Clocks for the Encoding of Time in Corticostriatal Circuits

The ability to predict when external events will occur, such as anticipating the actions of a predator or the
availability of food, is critical for survival. Converging computational and experimental work suggests that
dynamically changing patterns of neural activity, including neural sequences, underlie temporal prediction
and temporal processing. It is increasingly clear that timing and temporal prediction are highly distributed
computations, however, there has been little effort to systematically contrast and understand the
computational tradeoffs between how time is encoded in different brain areas. Furthermore, while
converging evidence suggests neural sequences in the striatum play a central role in timing, the
mechanisms underlying the generation of neural sequences remains elusive. Critically, it is not known
whether neural sequences are actively generated within the striatum or are “driven” by neural sequences
present in corticostriatal inputs. We propose to address these major gaps in understanding with a
combination of innovative experimental and computational approaches. Our key hypotheses are that: 1)
neural sequences in the striatum provide a flexible dynamical regime that allows for temporal scaling, i.e.,
speeding-up or slowing-down of motor responses, 2) cortical input shapes neural sequence formation in
the striatum, 3) local inhibitory circuits serve to refine the quality of these sequences in the striatum, and
4) neural dynamics encoding time are widely distributed throughout the brain but are more accurate in
certain areas such as the striatum. Our project is anchored in a two-interval timing task in which mice
learn to associate two cues with different reward delays, and has three major aims. Guided by large-scale
neural recordings in multiple brain areas we will first develop cortical and striatal recurrent neural network
models with the goal of understanding which circuit motifs are best suited to generate neural sequences,
and determining which models best capture the experimentally observed activity patterns. Second, we will
integrate neural recordings and optogenetic perturbations, together with computational approaches, to
determine whether neural sequences in the striatum are driven by cortical input and refined by local
inhibition, or in contrast actively generated within the striatum. Third, we will carry out a high-throughput
electrophysiological survey of neural activity in multiple brain areas, to identify which areas contain the
most accurate temporal codes as well as the potential computational tradeoffs between different codes.
RELEVANCE (See instructions):
By integrating advanced computational and experimental approaches, this collaborative project will
provide fundamentally new insights about how the mammalian brain is able to predict when external
events will occur, enabling animals to produce appropriately timed movements that are critical in daily life.
This work will reveal which brain circuits are most strongly implicated in timing, which is often impaired in
neurological disorders such as Parkinson’s and Huntington’s disease.